Metabolic Engineering of Bacteria for Cancer Immunotherapy by Gamma Delta T Cells

In the United States and throughout the world, cancer incidence and mortality has increased dramatically in
both developed and developing nations. Cancer causes ~13% of human deaths with 7.6 million people dying
from cancer in 2007. More people in the US die of lung cancer than breast, colon, kidney, and prostate cancers
combined. Recent studies show that veterans are 25 to 75 percent more likely to develop lung cancer than
people who did not serve in the military. Advances in cancer immunotherapy are leading to breakthroughs in
treatment. Adoptive transfer of T cells expressing chimeric antigen receptors (CAR-T) results in durable remis-
sions for B cell malignancies. Checkpoint blockade with antibodies against PD-1, PD-L1, and CTLA-4 results in
partial and complete responses in patients with a variety of malignancies. Yet, significant limitations exist. With
the exception of patients with melanoma, only a minority of patients respond to checkpoint blockage. Common
cancers such as prostate and colorectal cancer generally do not respond. Thus, additional approaches are
needed to realize the full potential of cancer immunotherapy.
Treatment with γδ T cells expressing Vγ2Vδ2 TCRs is one such approach. Unlike αβ T cells, the response
of Vγ2Vδ2 T cells is not MHC restricted but instead requires the Ig superfamily protein, butyrophilin 3A1, to
sense the foreign-microbial isoprenoid metabolite, HMBPP, and the self-metabolite, IPP. This sensing allows
tumor cells to be recognized and killed by Vγ2Vδ2 T cells independent of their mutational burden. Vγ2Vδ2 T
cells safely expand to very high numbers during many infections (up to 1 in 2 circulating T cells) where they kill
infected cells and secrete inflammatory Th1 cytokines, chemokines, and growth factors.
Two approaches are being used to treat cancer with Vγ2Vδ2 T cells. The first is to immunize with stimula-
tors such as the bromohydrin analog of HMBPP or the aminobisphosphonate zoledronic acid with low-dose IL-
2. Although treatment has resulted in partial remissions, these vaccines eventually cause anergy and deletion
of the Vγ2Vδ2 T cells. The second is to adoptively transfer Vγ2Vδ2 T cells. This approach is safe and has in-
duced complete remissions in three patients with solid tumors, and induced partial remissions or stable dis-
ease in others. However, for widespread adoption, Vγ2Vδ2 T cell therapy needs to be more effective.
Live bacterial vaccines have been used to prevent tuberculosis, typhoid fever, and tularemia. The bacteria
produce compounds that activate innate immunity and antigens that stimulate αβ T cells to provide help to the
Vγ2Vδ2 T cells as they expand. We have now identified an attenuated Listeria strain that consistently ex-
pands Vγ2Vδ2 T cells. Listeria preferentially accumulate in tumors which should allow the specific tar-
geting of adoptively-transferred Vγ2Vδ2 T cells to tumors as well as TCR stimulation at the tumor site
by HMBPP. We also find that Vγ2Vδ2 T cells rapidly express checkpoint receptors such as CTLA-4, PD-
1, TIM-3, and LAG-3 upon stimulation and that adding PD-1 checkpoint blockade markedly enhances
prostate tumor immunity by Vγ2Vδ2 T cells in a mouse model. We have also identified a novel
bisphosphonate prodrug. To accomplish these goals, we will: delete inlB in ΔactA prfA* (G155S) Listeria
vaccine and assess dosing and timing of immunization, assess the ability of Listeria bacteria to target and acti-
vate adoptively transferred Vγ2Vδ2 T cells to control tumors, and assess effectiveness of combining checkpoint
blockade and a new PTA bisphosphonate prodrug with adoptively transferred Vγ2Vδ2 T cells.
We have an outstanding team with an excellent track record and have extensive experience working with
γδ T cells and isoprenoid metabolism. We have established in vivo models and techniques. An effective Liste-
ria vaccine have been identified. The molecular methods to create more vaccines are well developed. In con-
clusion, immunotherapy using bacterial vaccines for Vγ2Vδ2 T cells has the potential to be broadly applicable
for the treatment of many different tumors both by direct activation and through potentiating adoptive transfer.

Public health relevance
Many studies have found higher rates of cancer incidence and mortality among veterans. In the United States, cancer accounts for 25% of all deaths with 30% of these from lung cancer. U.S. veterans who served in the Vietnam, Korean, or the 1991 Persian Gulf war are at high-risk for lung cancer since they are 25 to 75 percent more likely to develop lung cancer than people who did not serve. Also, veterans were exposed to various environmental hazards and microbial infections. Despite advances in our understanding of the causes of cancer, progress in treatment is still limited for many types of cancers especially solid tumors. Our vaccine will stimulate a type of blood cells called “gamma delta” T cells for treatment of a number of different tumor types by immunotherapy.